Developmental Contributions to the Functional Maturation of the Vestibulo-Ocular Reflex

PROJECT SUMMARY
During development, animal behaviors improve as neural circuits refine. Prior work suggests that early
developmental events, such as birth timing, define the role a neuron will play in a circuit. However, the
complexity of most developing circuits and the behaviors they subserve limit our understanding of the role of
early events in circuit maturation. My proposed experiments address this gap by asking if early development
shapes circuit maturation. Defining the relationship between development and function is key to understand
the how the brain and behavior mature in healthy and diseased states.
The larval zebrafish is a particularly tractable model for circuit development due to its genetic accessibility,
transparency, and rapid external development. Specifically, the neuronal populations driving gaze stabilization
following body tilts in the larval zebrafish are well-conserved and orders of magnitude smaller. Our lab
leverages these advantages to link developmental phenomenology with circuit maturation and behavior. We
have established genetic and optical means to longitudinally measure and manipulate neural activity across
development. Importantly, prior work from our lab has revealed that the birthdate of vestibular neurons
influences anatomical location within the brainstem and preferred direction of body tilt.
The goal of this proposal is to determine if birthdate similarly predicts how sensory responses
mature, and if birthdate predicts a neuron’s contribution to behavior. In Aim 1, I will determine if a central
vestibular neuron’s birthdate predicts its sensitivity to body tilts of different magnitudes, and/or how this
encoding matures. In Aim 2, I will examine how developmentally and functionally diverse populations of
vestibular neurons contribute to behavior using loss- and gain-of-function approaches. My data will define the
role of early development in circuit function. Completion of these experiments will speak to the general
mechanisms by which circuit function is influenced by – or indifferent to – early development.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental and childhood disorders often arise due to abnormal neural development impacting function. The proposed research is relevant to public health because defining the developmental processes driving and constraining behavior will serve to increase our understanding of human health and treatment of developmental disorders. Therefore, this proposal is central to the NIH’s mission to increase fundamental knowledge of the mechanisms of disease, disorders, and dysfunction that impair health.